Lead optimization of oral DHFR inhibitor for the treatment of multidrug-resistant N. gonorrhoeae infections.

Abstract. The development of new antibiotics for treating N. gonorrhoeae (Ng) is lagging behind
the rapid emergence of resistant strains. Ng has developed resistance to all FDA-approved
therapies and even to unapproved drugs like gepotidacin and solithromycin. This highlights the
scarcity of antimicrobials in clinical development, underscoring the urgent need to discover new
antibacterial agents, ideally oral drugs, that can target drug-resistant Ng. This SBIR Phase 2
proposal presents a significant opportunity to develop a narrow-spectrum oral therapeutic for Ng,
where existing first-line therapies fail. Our proprietary chemical class targets bacterial
dihydrofolate reductase (DHFR) and shows excellent in vitro potency, particularly against MDR
Ng clinical isolates. This class also boasts outstanding oral bioavailability, target selectivity, a
favorable resistance profile, acceptable toxicity profile, very good pharmacokinetic (PK), and
physicochemical/ADME properties. While inactive against other Gram-positive and Gram-
negative pathogens, the lead compounds TXA15054 and TXA16126 are potent against multiple
Ng strains, including ceftriaxone-resistant strains (WHO-X, WHO-Y, WHO-Z), and azithromycin-,
ciprofloxacin-, and tetracycline-resistant CDC isolates, with impressive low MIC values ranging
from 0.031 to 0.004 μg/mL. Biochemical and genetic methods have confirmed DHFR as the
primary target. TAXIS compounds exhibit negligible activity against human DHFR, with an IC50
selectivity ratio (human/Ng) exceeding 900-fold for both leads. These compounds also have
moderate aqueous solubility, high plasma and metabolic stability, and no CYP inhibition. Their
cytotoxicity and hERG selective window are several hundred-fold above Ng MICs, indicating a
favorable safety profile for clinical use. TXA15054 has excellent PK properties and an oral
bioavailability of 85%. Moreover, TXA15054 completely eradicated Ng in a mouse vaginal tract
infection model following oral administration, highlighting the importance of this proposal in
developing oral therapeutics for drug-resistant Ng infections. This application aims to optimize the
lead candidates by addressing three key liabilities: low intrinsic solubility, low therapeutic index,
and moderate cytotoxicity. Leveraging insights from early analogs, the multiparametric lead
optimization campaign will focus on eliminating these liabilities to produce two preclinical
candidates. We believe this SBIR grant will bolster our efforts to deliver a first-line oral treatment
for multidrug-resistant Ng infections.

Public health relevance
Project Title: Lead optimization of oral dihydrofolate reductase (DHFR) inhibitor for the treatment of multidrug-resistant Neisseria gonorrhoeae infections Project-Narrative: Due to ineffectiveness of existing antibiotics and the emergence of ceftriaxone-resistant strains threatening even the last-line option, N. gonorrhoeae became a priority pathogen for the World Health Organization’s (WHO) causing approximately 1.6 million new cases per year in US alone, out of which 50% are resistant to at least one antibiotic. With a commitment to developing a counterstrategy involving a novel chemical series of orally available narrow spectrum dihydrofolate reductase (DHFR) inhibitors, TAXIS pharmaceuticals has identified a set of lead compounds (TXA15054 and TAX16126) owing to their excellent in vitro potencies against drug (including ceftriaxone)-resistant gonococcal isolates, outstanding oral bioavailability, exceptional target selectivity, safe toxicity profile and in vivo efficacy (with TXA15054) against multidrug resistant N. gonorrhoeae in a mouse vaginal infection model via oral route. Further optimization of the series to improve its therapeutic index and solubility through multiparametric structure-activity relationship while keeping its desirable resistance profile, oral administration opportunity, and acceptable toxicity/physiochemical/ADME properties, might culminate to an orally available preclinical candidate targeting untreatable N. gonorrhoeae infections.